Molecular Studies of the Choriocapillaris in AMD

ABSTRACT
Age-related macular degeneration (AMD) is a common cause of severe vision loss. Recent studies have
shown that a layer of capillaries called the choriocapillaris is affected in AMD, both in “dry” AMD in
which the blood vessels degenerate, depriving the retina of nourishment, and in “wet” AMD in which
the cells become activated to grow abnormally, damaging the retina. To a large extent the biochemical
changes in the choriocapillaris that accompany AMD are poorly understood. In this proposal we will
study how a gene that is affected by the complement system and is enriched in AMD cells contributes to
the processes associated with the choriocapillaris in AMD. We will also utilize a new technology (single
cell RNA-sequencing) to discover the molecular signatures of endothelial cells from the choroid at the
single cell level of resolution in health and different forms of AMD. A better understanding of how these
cells are altered in disease will provide insight into how to protect them from damage and death.

Public health relevance
NARRATIVE Age-related macular degeneration (AMD) is a common blinding disease characterized by biochemical changes and atrophy of the blood vessels that supply the retina. Understanding how genes contribute to the dysfunction of these blood vessels will enable the creation of better treatments for AMD. In this research program we will study how an important gene affects the behavior of human blood vessel cells and will identify additional genes that distinguish between early AMD, “dry” AMD and “wet” AMD.